Prospective Microdata for Research on Aging

Project Summary/Abstract
This project will create a massive microdata resource comprising the entire population of the United States in
1950. The 1950 Census is ideal for research on aging: people who were young in 1950 can be linked to myriad
sources describing their health and well-being from mid to later adulthood, allowing a prospective view of aging.
By linking the 1950 Census to recent health surveys, administrative records, and the national death index,
investigators can pursue prospective analyses of the impact of early life conditions—including socioeconomic
status, parental education, local environment, and family structure—on later health and mortality. The database
will cover the entire population with full geographic detail, providing contextual information on childhood
neighborhood characteristics, labor-market conditions, and environmental conditions. The 1950 data will enable
transformative research to uncover the effects of early life conditions on health and well-being in later life,
including cognitive impairment. The database will make a permanent and substantial addition to the nation’s
statistical infrastructure and will have far-reaching implications for research across the social and behavioral
sciences.
The project involves (1) transcribing 8.3 billion keystrokes of data describing the demographic and economic
characteristics of all individuals, families, households, and group quarters present in the U.S. in 1950; (2)
evaluating data quality through random blind verification and comparison with published census tabulations; (3)
converting approximately ten million different open-ended census responses into numeric classifications
compatible with previous and subsequent census data; (4) data cleaning, including editing and imputation of
inconsistent and missing data values; (5) developing metadata and documentation, including full descriptions of
data processing methods, detailed analysis of comparability issues, and comprehensive machine-processable
metadata; and (6) incorporating the database into the Integrated Public Use Microdata Series (IPUMS) data
access systems for free dissemination to the scientific community.
The proposed work will be carried out by a team of highly-skilled researchers with unparalleled expertise and
experience in large-scale data creation, integration, and dissemination. The project is a collaboration with the
nation’s largest producer of genealogical data. This public-private partnership allows a highly cost-effective use
of scarce resources for shared infrastructure for population and health research.

Public health relevance
Narrative This project will develop data for prospective analysis of the impact of early-life circumstances and environment on health outcomes in late life, including Alzheimer’s disease. The creation of the proposed database is urgent and will provide a resource of unprecedented power for understanding the effects of public policies, social institutions, and environmental conditions on the health, well-being, and functioning of people, both over the life course and in their later years. The proposed work is directly relevant to the core mission of the Population and Social Processes branch of NIA, since the data will allow us to observe today’s late-life population when they were young.